The respiratory microbiome and its role in the host response to wood smoke

PROJECT SUMMARY/ABSTRACT
The respiratory microbiome was reported for the first time in 2010. Since then, various studies have shown that
the microorganisms in the respiratory tract influence respiratory health, as changes in the respiratory microbiome
have been associated with airway inflammation and various respiratory diseases, like asthma and allergic rhinitis.
While studies have reported dysbiosis of the microbiome with exposure to general pollutants like particulate
matter, the impact of climate change-dependent pollutants like wood smoke is currently unknown yet is likely to
have significant health implications. As wood smoke exposure events are growing worldwide due to wildfires, it
is critical that we learn more about the respiratory response to this exposure. Therefore, the overall objective of
this proposal is to characterize the structural and functional changes of the respiratory microbiota and its
metabolome after wood smoke exposure and identify the mechanism(s) by which the respiratory microbiota and
its metabolome modulate the host response to this exposure. The central hypothesis of this project is that the
respiratory microbiome is a significant component of the host response to wood smoke via metabolite-driven
host-microbiome interactions. Therefore, my specific aims will first (Aim 1) characterize the in vivo effects of
wood smoke on the respiratory microbiota and metabolome individually, followed by an innovative multi-omics
approach that integrates respiratory microbiome and metabolomics data to determine interactions. My second
aim (Aim 2) focuses on identifying the microbe-derived metabolites and metabolite-driven mechanisms that
modulate the host response to wood smoke. Here, I will study the in vitro effect of this exposure on the individual
components of host-microbiota interactions and their metabolite-driven crosstalk. The results of this proposal will
be significant as they will demonstrate for the first time that the respiratory microbiota has an active role in the
host response to wood smoke via metabolites, highlighting the importance of considering the respiratory
microbiome in inhalational toxicology. Furthermore, these results will identify microorganisms and
microorganism-derived metabolites with potential therapeutic and prophylactic properties against wood smoke-
induced respiratory adverse health effects. Notably, this project will provide multiple training opportunities in
microbiome analysis, metabolomics, and advanced computational analyses, such as multi-omics data
integration and machine learning, significantly advancing my goal to become an independent scientist.

Public health relevance
PROJECT NARRATIVE Wood smoke exposure has become a growing concern worldwide and has been linked to various respiratory adverse health outcomes, including airway inflammation and disease; however, the mechanism by which this occurs remains unknown. Given that changes in the respiratory microbiome have also been associated with airway inflammation and respiratory disease, investigating its role in the host’s response to wood smoke is significantly relevant to public health, as it offers potential therapeutic and preventive strategies against wood smoke’s adverse effects on respiratory health.